University of Michigan O'Brien Kidney Translational Resource Center (MKTC)

ABSTRACT – CENTER OVERVIEW
The main goal of the University of Michigan O'Brien Kidney Translational Resource Center (MKTC)
is to provide an effective translational research pipeline to develop novel, mechanistic treatment
strategies for patients with kidney diseases. The center will support all basic and patient-oriented kidney
research investigators using a 3-pronged approach: Enable investigators to investigate the molecular
causes and endpoints of acute and chronic kidney diseases; Dissemination and support of the most
modern and powerful systems biological approaches for all investigators to help them effectively identify
novel and robust biomarkers, endpoints and targets for diagnosis and treatment of AKI and CKD; Expert
analysis and integration of cohort and systems data for our research base investigators through the use
of sophisticated bioinformatics and database integration that promote identification of specific pathways
and targets for treatments for individuals or groups of subjects with AKI and CKD.
The Center's aims are to:
1) Introduce, stimulate and apply state-of-the-art systems biological approaches to kidney disease
research investigators through the use of sophisticated but user-friendly genetic, transcriptomic,
proteomic, metabolomic and lipidomic approaches through the Applied Systems Biology Core;
2) Enhance the understanding of complex kidney diseases and the multi-scalar data sets that
accompany systems biological approaches to their functional implications regarding kidney
disease development, diagnosis, progression and therapeutic potential through the Data Analytic
Services Core (DASC);
3) Serve as national resource and expand worldwide outreach efforts via Nephroseq, Nephrocell
and tranSMART;
4) Use the Student Programs and robust enrichment programs to entice trainees and faculty into
kidney research, improve diversity, equity and inclusion and support researchers in their ongoing
kidney research.
5) Share best practices and resources with the other National Resource Centers under the U54
consortium and work with Data Coordinating Center to enable widespread dissemination.

Public health relevance
PROJECT NARRATIVE Chronic kidney disease (CKD) and Acute Kidney Injury (AKI) remain a major health problem that causes substantial disability and premature death. The University of Michigan George M. O'Brien Kidney Translational Resource Center will provide researchers the opportunity to utilize advanced technologies by providing the necessary infrastructure and tools to improve care of patients with AKI and CKD. Through its research cores, enrichment activities, and community outreach, it will serve as a national resource for enabling new discoveries and enhance scientific progress supporting cutting-edge basic, clinical and translational kidney research.